Development and Production of Standardized Reference Diets for Zebrafish Research

Project Summary
The over-arching goal of this Phase II SBIR proposal is to optimize and implement high quality standard
reference diets for the Zebrafish (Danio rerio), an animal model of critical importance to the understanding of
human health and development of vertebrate organisms. A key problem in the industry is that high quality
standardized reference diets, with appropriate physical properties and adequate feed management strategies,
have not been developed for D. rerio. Our solution for the industry, driven by a synergistic collaboration
between Meridian Biotech and the laboratory of Dr. Stephen Watts at the University of Alabama at
Birmingham, is to develop several open formulation diets for larval, juvenile and adult Zebrafish, which will
achieve a desired level of control and whereby use of this modern and effective biomedical animal model is
substantially improved and more standardized. This commercial-academic collaboration is a significant value
add to this applied science program. Key ingredients in this formulated diet will include protein packages that
contain defined and effective sources, including a microbial based Single Cell Protein (SCP), an enriched
protein source obtained from bacterial biomass. Diets with these protein sources have been developed by
Meridian Biotech, several of which have improved shrimp and fish farming feed technologies markedly; thus,
we wish to apply this technology to D. rerio and, potentially, other relevant animal models. Our mutual Phase II
Milestones and Specific Experimental Aims are many across both years of the program. Specific Aims for
Milestone 1 (Year 1 work) include optimizing the protein content and amino acid profile of our most promising
ingredient and testing it against the existing SCP-fortified diet used in pilot Phase I work, comparing the best
diet to the competitor diets currently used in academic cores across the US biomedical research enterprise,
and characterizing deeply at the phenotypic and genetic levels the benefits of our diet. Milestone 1 will seek to
identify and progress the best diet and drive its market penetration, initially in academia. Specific Aims for
Milestone 2 (Year 2 work) include further optimizing the amino acid, fatty acid, neutral fat, and energy of the
SCP ingredient and scaling up manufacturing to meet demands at Meridian’s new US-based facilities, sharing
the best diet formulation with academic Zebrafish cores to drive adoption of the diet, and centralizing the data
gathering from the many academic cores for use by all and the NIH ORIP. Milestone 2 will seek to penetrate
the academic Zebrafish husbandry marketplace by gaining Core adoption. In parallel with collaborative efforts
within the academic marketplace, Meridian and commercial partners across both years will also pursue a
Milestone 3 which seeks to expand the technologies and penetrate the industry fish aquaculture and farming
marketplace, other production species, and potentially develop human applications.

Public health relevance
Project Narrative A key problem in Zebrafish (Danio rerio) husbandry science and industry is that a high-quality standardized diet, including optimized physical properties and feed management strategies, has not been developed for this important vertebrate animal model. Our solution for the industry, driven by a synergistic collaboration between Meridian Biotech and the laboratory of Dr. Stephen Watts at the University of Alabama at Birmingham, is to develop optimized ingredient profiles (based on bacterial-based single cell protein source) for an open formulation standard reference diet for larval, juvenile and adult Zebrafish, that will achieve a desired level of control and whereby use of Zebrafish as a modern and effective biomedical animal model is substantially improved and standardized. Given the utility of the Zebrafish as an animal model for human health, and coupled with the concomitant investment of research dollars, it is imperative that we develop open, high quality standard reference diets to add to the confidence, reproducibility, and exchange of results derived from this important animal model.